Addressing HIV drug resistance research gaps in a cohort of perinatally infected Kenyan children and adolescents

PROJECT SUMMARY
HIV drug resistance may compromise the UNAIDS 90-90-90 treatment goals and is a major hurdle to
sustainable antiretroviral therapy success. Though resistance testing is recommended by guidelines for patient
care in developed countries, there are existing research gaps in its understanding; genotypic-phenotypic
correlations in diverse HIV-1 subtypes, the relationship between minority drug resistance variants and
treatment outcomes, and reasons for discordances between genotype and treatment success or failure remain
unclear. These research gaps are of particular concern in resource-limited settings, where limited medications
and sub-optimal monitoring are common; and in children and adolescents, a vulnerable population with the
need for life-long therapy, who have higher levels of HIV-1 RNA, a wider treatment gap with fewer on therapy,
lower rates of suppression, limited formulations and more non-adherence. The long-term goal of our research
team is to provide new evidence to improve the clinical disease management children and adolescents living
with HIV in resource-limited settings. The purpose of this proposal is to address existing drug resistance
research gaps in a previously established, carefully characterized cohort of 499 children and adolescents living
with HIV in Kenya. To do this, we will use our successful collaboration with the Academic Model Providing
Access to Healthcare (AMPATH) in Kenya, one of the largest HIV programs in sub-Saharan Africa, and
uniquely leverage existing resources from our ongoing R01 AI120792 on perinatally-infected children and
adolescents at AMPATH (MPI Kantor and Vreeman). We hypothesize that comprehensive investigations of
genotypic-phenotypic and resistance-treatment outcome discordances in diverse non-B subtypes will resolve
some of these existing research gaps and optimize patient care in settings where it is most needed. We will
address this hypothesis with the following Aims: (1) Investigate genotype-phenotype correlations; (2) Evaluate
etiologies for treatment failure in the presence of a ‘susceptible genotype’; and (3) Evaluate etiologies for
treatment success in the presence of a ‘resistant genotype’. To achieve these aims, we will use already
available samples (collected between 2016-2018) from the existing cohort of Kenyan children and adolescents
living with non-B subtypes (Aim 1); longitudinally follow the cohort for four years (Aims 2 and 3); collect blood
samples bi-annually and assess adherence; identify participants that are eligible for proposed additional
investigations; conduct in vitro phenotyping to examine genotypic-phenotypic correlations; and perform near
full-length next generation sequencing on RNA and DNA to investigate minority resistance variants and
alternative mechanisms of resistance. The proposal is innovative in the uniqueness of the cohort studied, the
comprehensive proposed scientific investigations, and study design and evaluation of discordant genotype-
treatment outcomes scenarios. These investigations and directly addressing the existing knowledge gaps in
HIV-1 drug resistance in a particularly-vulnerable population with diverse non-B subtypes, will have a high
impact on improving treatment outcomes in children, adolescents, and adults living with HIV.

Public health relevance
PROJECT NARRATIVE This study will investigate existing knowledge gaps related to the development of drug resistance to common medications for HIV among a large, well-characterized cohort of children and adolescents living with HIV in western Kenya. The proposed research is highly relevant to public health since it will fill knowledge gaps in the scientific literature, which will lead to better interpretation of drug resistance tests in this population, improve clinical management and reduce HIV-related sickness and death. The long-term goal of this research is to provide evidence to improve clinical guidelines and disease management for children and adolescents living with HIV in resource-limited settings.